Training Institutes for mobile health (mHealth) methodologies

The promise of mobile technologies in fostering health-behavior change (mHealth), particularly in
behavioral and substance addictions, has been largely unrealized. Siloed development of mHealth solutions, an
absence of shared vocabulary, and a dearth of cross-disciplinary interactions are some of the underlying drivers.
Version 3.0 of our annual mHealth Training Institute (mHTI) will refine and extend our impactful capacity-building
and knowledge-transfer activities. It will expand the focus beyond training participants in cross-cutting mHealth
methodologies to include the development of integrative and collaborative abilities essential for tackling complex
healthcare problems. Distinctive elements of the mHTI 3.0 include: (a) a focus on advanced topics and edge
mHealth methodologies/analytics; (b) an articulated logic model to anchor program design, implementation and
evaluation of mHTI’s effectiveness; (c) Multidisciplinary Team Projects (MTPs) to promote team science and
emphasize impactful research; (d) use of advanced Social Network Analyses (SNA) to characterize the
development of integrative thinking and evaluate collaboration and communication patterns in the participants;
(e) use of innovative longitudinal SNA techniques, e.g., Separable Temporal Exponential Random Graph Models
(STERGMs) and Stochastic Actor-oriented Models (SAOMs), to examine dynamic team science processes; (f)
a novel digital platform (mHealthHUB) to promote and sustain transdisciplinary collaborations and broad
dissemination of curated didactic content; (g) use of the Flight Tracker software to track and understand post-
mHTI career trajectories via automated data collection; and (h) independent effectiveness evaluations by UCLA
School of Education & Information Sciences faculty who with use the mHTI 3.0 as a testbed to empirically
examine the processes by which teams organize, communicate, and conduct mHealth research.
The mHTI will continue to serve as a national resource and educational ecosystem, nurturing the next
generation of integrative scholars able to apply the latest advances in mHealth to the development and
implementation of solutions with practical societal impact. Our virtual collaboratory (mHealthHUB) will enable
and sustain collaborations between geographically dispersed scholars and ensure that the curated didactic
content and Open Educational Resources (OERs) from the annual mHTIs are freely available; thus, expanding
the reach and impact of our educational program and promoting long-term educational sustainability. The
didactic resources of each mHTI will be curated into content clusters to serve as a toolkit for mHTI scholars
seeking to deliver similar mHealth and team science training at their home institutions (Train-the-Trainer). By
continuing to prime the mHealth innovation pipeline with a diverse cadre of self-actualizing, integrative scientists
with transdisciplinary competencies and mindsets, mHTI 3.0 will ensure that the fields of behavioral health and
addictive disorders are better positioned to realize the transformative potential of mHealth.

Public health relevance
Public Health Relevance Statement To address the growing need for mHealth scientists who can integrate diverse scientific approaches and work in transdisciplinary teams, the UCLA mHealth Institutes will provide an innovative training program that will offer the didactic and team science experiences essential for solving complex behavioral health problems.